The Harvard Chan Education Program in Cancer Prevention and Control

Program Summary
The Harvard Education Program in Cancer Prevention and Control, in its 29th year, is a dynamic
transdisciplinary collaboration that brings together the extensive expertise of the Harvard T.H. Chan School
of Public Health, the Dana-Farber Cancer Institute and Dana-Farber/Harvard Cancer Center, and Harvard
Catalyst, o u r Clinical and Translational Science Center. We have trained 126 (61 predoc, 65
postdoc) fellows in transdisciplinary approaches to cancer prevention and control, and over 80% of
trainees hold a research- focused position. In the current cycle, we have met or exceeded all of our
benchmark goals. In this renewal, we are requesting continued support for 4 predoctoral and 4
postdoctoral trainees each year who have an average length of training of 4-5 years and 2 years respectively.
The overall goal of the Program is to train fellows to become the next generation of scientists who are: (1)
knowledgeable about the current state of the science of cancer prevention and control; (2) skilled in
transdisciplinary research; (3) skilled in formulating and writing research proposals and scientific manuscripts
for publication; and (4) anchored in peer and professional networks that support continual professional
development and access to resources to translate their knowledge into new cancer research areas.
Transdisciplinary training is further enhanced by leveraging our transdisciplinary PhD program in Population
Health Sciences that integrates training in five public health disciplines, and by instituting continuing to
enhance our evidence-based approach to mentorship training. We conducted a strategic evaluation of the
program, as it enters its 30th year, and have developed additional activities to address areas for growth. We
will continue our training focus in 4 areas of emphasis: (1) cancer equity; (2) implementation science; (3)
health communication; and (4) global cancer prevention. We also are enhancing our efforts in evidence-
based culturally aware mentorship training. Robust and engaged internal and external advisory
committees, and 33 very strong mentors with extensive research portfolios ensure that the program will
continue to thrive and innovate in cancer prevention training. The maturity of this Program, extensive
resources available through Harvard and synergy across the focal training areas provide an outstanding
platform for training the next generation of cancer prevention scientists.

Public health relevance
Project Narrative This training program is in its 29ᵗʰ year, and has trained 126 fellows in transdisciplinary approaches to cancer prevention and control. Over 80% of trainees are in research positions, and approximately 30% of trainees have come from underrepresented minority (URM) backgrounds (38% in current cycle). The maturity of this Program, extensive resources available through Harvard and synergy across the focal training areas provide an outstanding platform for training the next generation of cancer prevention scientists.